The Role of HIF2 in Pancreatic Ductal Adenocarcinoma

PROJECT SUMMARY/ABSTRACT
Pancreatic ductal adenocarcinoma (PDAC) contains a desmoplastic stroma that limits blood perfusion and thus
the delivery of nutrients, oxygen, and therapeutics, creating a hypoxic microenvironment that is able to resist
nearly all forms of treatment, including immunomodulating therapy. Cancer-associated fibroblasts (CAFs) are
the main components and producers of stroma in PDAC. The hypoxia-inducible factors-1 (HIF1) and -2 (HIF2)
are stabilized in low oxygen and have been hypothesized to mediate therapeutic resistance and aggressive
growth of PDAC, but deletion of HIF1 or HIF2 in the pancreatic epithelial compartment produced no obvious
phenotype in PDAC. Thus, we reasoned that HIF may instead be supporting PDAC pathobiology through its
functions in cancer-associated fibroblasts (CAFs), which are the other major cellular component in pancreatic
tumors. Since little was known about the role of HIF in the stromal compartment, we created a mouse model
that exploits two recombinases enabling us complete spatiotemporal control of tumor growth and HIF ablation
in CAFs. Using this model, we found that the abrogation of HIF2 in CAFs decreased tumor growth and doubled
the median survival of animals with pancreatic cancer. The loss of HIF2 in CAFs correlated with fewer
intratumoral M2 macrophages and regulatory T cells. Furthermore, conditioned media from hypoxic CAFs
produced similar effects in ex vivo assays even after boiling. These preliminary data suggested a HIF2-
dependent crosstalk between CAF and the immune compartment that may be critical to the ability of PDAC to
evade the immune system. Building on this preliminary data, we propose to identify the molecular mechanisms
that allow hypoxic CAFs to modulate the immune microenvironment of pancreatic cancer through three aims.
In Aim 1, we will determine the molecular mediators of HIF2-dependent crosstalk between CAFs and
macrophages. We will use mass spectrometry to identify the HIF2 dependent factor secreted from CAFs
capable of inducing M2 polarization in macrophages and determine how this factor is produce in CAFs and
how it alters macrophage function. Aim 2 will define the HIF2-dependent relationships between CAFs and T
lymphocytes. We will explore how CD8+ suppression and Treg conversion is regulated by HIF2 signaling in
CAFs using mouse models and co-culture methods. Lastly, in Aim 3, we will repurpose HIF2 inhibitors from
their current indications in renal cell carcinoma to pancreatic cancer as a drug to enhance immunotherapy
responses. The proposed research is significant because pancreatic cancer does not respond to
immunotherapy, and our data suggests that HIF2 inhibition may greatly improve immune responses. This
research is innovative because we will provide the first description of the immune-targeting molecular
pathways activated by hypoxic microenvironment in PDAC. Further, we will offer the first mechanistic
evaluation of a potential therapeutic combination using a HIF2 inhibitor along with immune checkpoint
blockade as the first steps towards clinical translation.

Public health relevance
PROJECT NARRATIVE Pancreatic ductal adenocarcinoma (PDAC) responds poorly to immunotherapy and the mechanisms of this resistance are unknown. We hypothesized that cancer-associated fibroblasts (CAFs) mediate this intratumoral immunosuppression in a HIF2-dependent fashion and provide evidence that HIF2 inhibition improves survival in mouse models of PDAC by potentially improving immune responses. In this grant, we explore the mechanisms of HIF2-dependent immune modulation by CAFs and perform preclinical studies to repurpose an FDA-approved HIF2 inhibitor to improve the response of pancreatic cancer to immunotherapy.